Enhancing communication on relationship preservation, safer conception and PrEP to promote HIV testing

PROJECT SUMMARY
Optimizing uptake of HIV testing is critical to meeting 95-95-95 goals in sub-Saharan Africa. As 30% of new
infections in occur within married or cohabitating couples, maximizing testing among individuals who are or
may someday be in serious heterosexual relationships has been identified as one of the most cost-effective
strategies to curb the epidemic. Childbearing is highly valued throughout Sub-Saharan Africa, and fears of
relationship dissolution and loss of the ability to have children remain significant barriers to HIV testing. The
expanding availability of pre-exposure prophylaxis (PrEP) presents an opportunity to counter these fears with
strategic communication (NOT-MH-21-105) that reassure couples of their ability to have a healthy family even
if one or both members are HIV positive. Our long-term objective is to leverage the growing availability of PrEP
to determine if and how a communication strategy focused on relationship preservation and safer conception
can increase testing and entry into treatment (antiretroviral therapy) or prevention (PrEP) among partnered
individuals in Uganda. We recently successfully piloted this communication strategy within Uganda’s assisted
partner notification program (APN). In this R34, we will: (1) conduct formative research to expand the
communication strategy into a multi-component intervention with broader reach; and (2) conduct a pilot trial of
the intervention, PrEPing Healthy Families. To achieve Aim 1, we will work with a community advisory board
(CAB) of providers to a) create communication materials (brochures, scripts) and counseling protocols tailored
to clients and partners across the array of couples’ testing pathways in APN and antenatal care (ANC). As
CAB providers pilot materials and tracking systems with clients and partners during this development phase,
study staff will conduct field observations and qualitative interviews focused on feasibility and acceptability,
informing revised intervention materials. To achieve Aim 2, we will collect baseline data at APN and ANC
clinics within two large public healthcare facilities over nine months. Sites will then be randomized to implement
PrEPing Healthy Families or their existing communication approach (usual care) over the next nine months.
We will collect mixed-methods data on feasibility and acceptability through intervention tracking in APN/ANC
registers, client exit surveys, and qualitative interviews with clients, partners and providers. Through register
extraction, we will examine limited efficacy on outcomes that would be relevant to a larger trial (partner HIV
testing, client service uptake initiation of PrEP/ART), and explore potential moderators. Overall, results will
yield important insights in a promising new communication strategy (NOT-MH-21-105) that may connect more
individuals to the HIV cascades of care for treatment or prevention and prepare us for a large-scale, cluster
randomized controlled trial to determine impact on testing and initiation of PrEP/ART.

Public health relevance
PROJECT NARRATIVE In Uganda, fears of relationship dissolution and loss of the ability to have children remain major barriers to HIV in heterosexual couples. Our communication strategy aims to promote HIV testing with reassuring messages about the ability to have stable relationships and healthy families with the increased availability of pre-exposure prophylaxis (PrEP). We will evaluate the feasibility and acceptability of this communication strategy among clients and partners within assisted partner notification and antenatal care programs in two hospitals and evaluate preliminary effects.